Deconstructing aging with senolytic CAR T cells

SUMMARY
Gaining a better understanding of aging biology is a pressing health and socioeconomic issue. In this regard,
cellular senescence is a key, but poorly understood determinant of organismal aging. Senescence is a stress
response program characterized by stable cell cycle arrest. Initially described as a tumor suppressor
mechanism, it involves the interplay between the tumor suppressors p53 and RB leading to a transcriptional
program of gene repression that silences proliferation associated genes. Beyond their arrest, senescent cells
secrete the senescence associated secretory phenotype (SASP) composed of cytokines and matrix
remodeling enzymes. The SASP contributes to the induction of paracrine senescence as well as to the
recruitment of immune cells, whose role is to clear the senescent cells and restore tissue homeostasis. Indeed,
this is what happens in the context of wound healing or tumor suppression. However, for mechanisms that
remain unclear, in certain settings such as aging or age-related diseases, senescent cells accumulate over
time generating a pathological chronic pro-inflammatory milieu that plays a key role in the pathophysiology of
these conditions. Our goals are to identify cell surface markers that are selectively expressed in senescent
cells in aging for the purpose of better identifying, isolating and characterizing the senescence program in
aging. In parallel, we will exploit the selective features of these molecules with the aim of developing better
imaging strategies to monitor senescent cells in vivo as well as of developing CAR T cells able to selectively
eliminate senescent cells in aging. We will use these senolytic CAR T cells to functionally interrogate
senescence biology in vivo as well as to study their therapeutic potential in preclinical models of age-related
diseases. Preliminary data strongly supports the feasibility of the proposed work: we have already identified
one cell surface molecule expressed on senescent cells in aging and validated the potential of CAR T cells
targeting it as effective and safe senolytics in aging. In our application, we continue to identify and validate
additional markers, characterize the molecular program of senescence in aging and optimize cellular therapy
designs for aging conditions. Cold Spring Harbor Laboratory has a longstanding history of nurturing successful
early scientist through their Independent Fellows program. This highly supportive environment is an ideal niche
to develop this project and launch my own research program as an Independent Fellow. Completion of the
proposed work will better define the senescence state in aging, produce new insights into the biology of
senescence immune surveillance and generate a new modality to both interrogate senescence and treat age-
related diseases.

Public health relevance
NARRATIVE Cellular senescence is a key but poorly understood determinant of organismal aging. Our proposal aims to identify surface molecules of senescent cells in aging which will allow us to image, isolate and characterize them. By harnessing cellular therapy directed against these surface targets we aim to flexibly interrogate senescence biology in aging and develop a new treatment modality for age-related diseases.